Cancer Research Training and Education Coordination

PROJECT SUMMARY/ABSTRACT
The Cancer Research Training and Education Coordination Core (CRTEC) of Perlmutter Cancer Center (PCC) at NYU Langone Health (NYULH) coordinates and supports educational activities aimed at training the next generation of researchers, clinicians, and professionals across the entire spectrum of cancer biology, prevention, and care. CRTEC is directed by Mark Philips, MD, an internationally recognized cancer cell biologist with a distinguished career in teaching and mentoring at all levels. Philips is also the Director of the NYU Medical Scientist Training Program, providing an important liaison for the PCC. He is assisted by a varied Advisory Board of stakeholders with important educational roles in multiple NYULH departments. CRTEC interacts with multiple entities across NYULH and the greater NYU campus, including the top-ranked NYU Grossman School of Medicine (NYUGSoM), a comprehensive biomedical sciences PhD program (Vilcek Institute) with 11 cancer-related T32 grants, a renowned MD/PhD program, post-graduate residency and fellowship training programs in medical, radiation, pediatric, gynecological, and surgical oncology as well as undergraduate, graduate, and professional programs in related fields, such as bioinformatics, social work, global health, nursing, dentistry, and engineering. The programs all place priority on ensuring a broad and successful student/trainee population. NYULH is a nationally recognized laboratory for educational innovation and CRTEC is a major contributor to these efforts. For example, CRTEC oversees highly successful outreach programs to attract high school and college students, particularly those from lower income communities to cancer-related careers, and it organizes the robust repertoire of educational activities and events intrinsic to the PCC. In the next cycle, it will extend these efforts to middle school students, engage a new high school adjacent to our campus intended to educate health care professionals, develop a new cancer- focused elective for senior medical students, expand programs to train clinical research nurses, develop quantitative methods to track and monitor trainee success, and support the educational components of SPOREs and other large grants. CRTEC has three Specific Aims: 1) Support and bring cancer-focus to the educational enterprise at NYULH, 2) Provide support, leadership, and infrastructure for the educational activities intrinsic to PCC, 3) Develop new initiatives in cancer education.